Spatial Heterogeneity in PIK3CA-Mutated Lymphatic Malformations

Project Summary
Lymphatic malformations (LM) are a common vascular malformation of the head and neck in children, affecting
1-in-4000 live births. LM of the head and neck can be disfiguring and cause life-threatening dysfunction,
including airway obstruction and impaired swallowing and speech. LM are caused by defective morphogenesis
of lymphatic vessels and surrounding tissue overgrowth due to post-zygotic activating mutations in the
oncogene PIK3CA. Interestingly, less than 10% of cells in LM are mutant. Data on how such a small number of
mutant cells produce bulky, complex LM are lacking, but localized, intralesional paracrine signaling must play a
role.
The experiments proposed here aim to elucidate LM pathophysiology using a combination of spatial
transcriptomics and in situ single cell genotyping. We will use NanoString to obtain high-throughput spatial
analysis of RNA and protein expression data for different cell types and regions of interest in LM tissue.
Although we expect to find evidence of PI3K-AKT pathway hyperactivation in both lymphatic endothelial cells
(LECs) and LEC-adjacent cells, we hypothesize that gene expression programs will vary based on LEC
proximity. We also propose the use of STAR-FISH (specific-to-allele PCR–FISH) in situ genotyping to define
the mutation status on a single cell level in the context of LM architecture. We hypothesize that while LECs will
represent the main class of mutant cells, there will be non-LECs containing PIK3CA mutations, and mutant cell
distribution will correlate with regions that demonstrate pathway hyperactivation.
Understanding the spatial expression programs and genetic heterogeneity in LM will inform the molecular
impact of a single activated oncogene on LM formation and persistence, thus guiding further development and
utilization of targeted therapies for these and other vascular malformations. Knowledge from this investigation
has broad implications for understanding other mosaic disorders and tumor heterogeneity.
The proposed project will be completed under the mentorship of Dr. James Bennett and Dr. Jonathan Perkins,
as part of a structured research training program that includes formal coursework in genetics, statistics, and
bioethics and training in grant writing, manuscript preparation, and research communication.

Public health relevance
Project Narrative Lymphatic malformations (LMs) are a common developmental malformation consisting of a mass of overgrown lymphatic channels. Mutations in the oncogene PIK3CA drive the formation of LMs, but surprisingly these mutations are typically present in less than 10% of cells in the lesion. By better understanding the precise location of the mutant cells and their corresponding gene expression programs within intact human LM tissues we will advance our understanding of how these malformations develop, improve the development of novel therapies, and improve the lives of individuals with vascular malformations and other mosaic disorders in general.